The Role of Spousal Biobehavioral Co-regulation in Everyday Collaborative Memory: Identifying Targets for Intervention

Project Summary/Abstract
Significant work demonstrates the influence of spouses on one another’s emotions, behaviors, and health-
related outcomes. What is not understood is the role partners play in cognitive development, change, and
adaptation in middle and later life. Because researchers have not identified the biobehavioral mechanisms and
processes that couples employ as they navigate normative and non-normative (i.e., mild cognitive impairment,
dementia) cognitive aging, development of effective behavioral interventions to maintain and bolster
performance is impeded. Prospective memory (PM), or memory for future actions, is essential to health and
safety (e.g., remembering to take medication or turn off a stove) and ultimately, the ability to age in place. To
remain in their homes, older adults must maintain this critical memory skill. The proposed research will identify
behaviors of middle-aged and older adults when they collaborate on PM tasks and determine how those
behaviors and the accompanying stress response affect PM. The central hypothesis underlying this research is
that significant others are inherently involved in daily memory tasks and exert substantial “partner” effects,
which positively (e.g., compensation) and/or negatively (e.g., retrieval interference, increased stress) influence
PM outcomes. To test the hypothesis, this research addresses four specific aims: 1) Determine the effects of
individual and dyadic characteristics on collaborative PM performance in laboratory and real-world contexts, 2)
Investigate social and cognitive behaviors exhibited during the collaborative process to determine the impact of
dyadic behaviors on PM performance, 3) Identify the concomitant effects of partners’ stress responses and
ability on collaborative PM performance, and 4) Investigate biobehavioral processes and corresponding
performance within a clinical subsample of dyads for whom one partner has MCI or early-stage dementia. The
research is significant because it systematically examines the commonplace (but unstudied) phenomenon of
partner interactions to identify the socio-cognitive and physiological processes important to PM and how these
biobehavioral pathways may differ for couples experiencing non-normative cognitive change. The work is
innovative because it includes measurement of dyadic attunement and incorporates investigation of spouses
who experience cognitive change at different rates and thus are faced with the need to compensate for a
partner who is struggling with the cognitive tasks of daily life. The proposed research is essential to achieving
our goal of developing behaviorally-based interventions to enhance critical everyday memory behaviors and
promote independent living.

Public health relevance
Project Narrative Successful memory for future actions is essential to adults’ capacity to engage in health and safety-related activities (e.g., remembering to take medication). Unfortunately, limited knowledge exists regarding the processes that couples employ as they navigate both normative (e.g., forgetfulness) and non-normative (i.e., mild cognitive impairment, dementia) cognitive aging, thereby impeding intervention development. This research investigates the biobehavioral pathways (i.e., physiological stress response, behaviors, and social processes) which positively and negatively impact middle-aged and older spouses’ prospective memory performance in order to achieve long-range intervention outcomes that will: positively impact couple resiliency, reduce everyday memory failures, and ultimately allow more older adults to age in place.